RADX INNOVATION FUNNEL FOR HEALTH TECHNOLOGIES - AWARD MANAGEMENT, TASK ORDER 005

The goal of the Commercialization Center for the RADx Innovation Funnel for the GAMBIT Fetal Sequencing Initiative is to accelerate regulatory review and availability of high-quality, accurate, and reliable diagnostic tests to the public. The Commercialization Center is a trans-NIH focused activity that provides professional services support across a range of commercialization domains to NIH translational activities.